Institutional Career Development Core

Project Summary/Abstract
The prevalence of aging adults with Down syndrome (DS) has increased dramatically in the past few decades
as their life expectancy has more than doubled. Most adults with DS will develop pathology associated with
Alzheimer’s Disease (AD) as early as age 31. By age 65 the cumulative incidence of dementia exceeds 90%
and is the leading cause of death in adults with DS. AD in adults with DS is associated with reduced functional
independence and associated increased burden on their caregivers. Increased physical activity is associated
with improved physical function and performance of activities of daily living in typically developed adults with
dementia, resulting in reduced burden for their caregivers. However, interventions designed to increase
physical activity in adults with DS and reduce caregiver burden are currently unavailable.
Reducing Disability in Alzheimer’s Disease (RDAD) is a 12-week intervention designed for typically developed
adults and their caregivers delivered during home visits. RDAD includes increased physical activity for the
adult with AD and training for caregivers in the management of dementia-related behavioral symptoms and has
been shown to be effective in typically developed adults with dementia and their caregivers. Data from a small
sample of adults with intellectual disabilities, including DS, suggest the potential efficacy of the RDAD
approach for increasing physical activity and reducing behavioral symptoms in adults with intellectual
disabilities and reducing burden in their caregivers. However, RDAD is not tailored to the unique needs of
adults with DS and their caregivers and is delivered by interventionists during individual home visits which
limits the potential for reach, adoption, implementation, and maintenance of the interventions. Our objective is
to support the training of Dr. Amy Bodde through an NIH INCLUDE initiative KL2 Scholar slot. This training will
include didactic and mentored experiential opportunities to develop her skills in: 1) clinical and translational
research, including adapting evidence-based interventions, remote delivery of physical activity interventions,
assessment of intervention usability, feasibility, safety, acceptability and efficacy, and dyadic analysis; 2) the
physiologic and psychosocial aspects of the development, identification and care of dementia in adults with
DS, and; 3) professional development required to become an independent clinical investigator. Completion of
the proposed training and research plan to adapt and evaluate the feasibility of RDAD for Down syndrome
(RDAD-DS) will provide Dr. Bodde with the knowledge and experience to move forward with her research
career and will generate preliminary data to inform the development of a proposal to seek R01 funding to
conduct an adequately powered randomized Stage II/III trial to evaluate the efficacy of the RDAD-DS
intervention. If ultimately shown to be successful, the remotely delivered RDAD-DS intervention has the
potential for significant public health impact for adults with DS and their caregivers.

Public health relevance
Project Narrative Individuals with Down syndrome (DS) experience premature aging and high rates of Alzheimer’s disease (AD) and associated declines in physical function which are associated with increased caregiver burden. Interventions to increase physical activity may improve or maintain physical function in aging adults with DS and reduce burden on their caregivers, who are often parents facing their own age-related functional declines. This project will adapt an evidence-based intervention developed for use in typically developed adults with AD which combines physical activity and caregiver training in behavioral symptom management to the needs of those with DS and evaluate the potential for the adapted intervention to improve functional and health parameters in adults with DS and reduce caregiver burden.